Incentives and ReMINDers to Improve Long-term Medication Adherence (INMIND)

Project Summary
Recently the number of people initiating antiretroviral (ART) treatment (“treatment initiators”) has increased but
too many fail to achieve viral suppression. Healthy routines are key to achieving long-term behavioral change
and healthy outcomes, but few people manage to form them on their own. Existing interventions typically
suggest that people anchor the targeted behavior to an existing routine, but fail to support participants during
the time it takes to turn the behavior into a routine, with the result that typically fewer than half end up carrying
the targeted behavior out automatically. Behavioral economics (BE) points to two important biases preventing
many people from translating their good intentions into successful routines; it also suggests two readily
implementable approaches to counter these same biases: the bias of lack of salience of chronic treatment
adherence (i.e. over time, the more pressing needs of daily life dominate good intentions) can be countered by
low-cost reminder messages sent via mobile phone during the time it takes to turn pill-taking into a routine
behavior. Present bias (i.e. giving in to short-term temptations, which can lead to skipping pill doses) explains
why many people have trouble sticking to their good intentions. Using small, intermittent incentives until the
behavior becomes a routine is a novel approach that has the potential to be a game changer for establishing
the (currently elusive) goal of long-term high ART adherence. The proposed R34 study will be implemented in
a Ugandan HIV clinic in a 12-month randomized controlled trial (RCT) among treatment initiators to establish
feasibility, acceptability, and preliminary efficacy of the intervention. Following formative work in Phase 1, all
study participants will be told about the importance of routine pill-taking and receive a leaflet with strategies for
anchoring pill-taking to an existing routine. Participants in the first intervention group (n=50) will then receive
daily text messages for 3 months to reinforce that information (Message group). Participants in the second
intervention group (n=50) will receive the same messages, but will also have a chance of winning small
rewards conditional on high and timely medication adherence (Incentive group). Participants in the Control
group will receive the usual standard of care. Persistence of adherence (primary outcome) and timely pill-
taking (secondary outcome) will be measured using MEMS caps for 9 months after the 3-months intervention,
and retention in care as well as viral loads (secondary outcomes) will be assessed at month 12. Specific Aim 1
will be to evaluate the feasibility and acceptability of INMIND and develop the intervention using the ADAPT-
ITT framework. Based on these insights, Specific Aims 2a and 2b will test the preliminary effectiveness of the
intervention, including the relative effectiveness of two different implementation approaches (i.e. text messages
alone vs. together with small BE-based incentives). Specific Aim 3 will collect data allowing adaptation of
intervention parameters for a subsequent R01 application to test the intervention at scale.

Public health relevance
Project Narrative For public health it is important to support the growing number of ART treatment-initiating clients who often fail to achieve viral suppression, with catastrophic consequences in particular in resource-constrained countries in which treatment options are limited. This study aims to increase ART adherence among treatment initiators by anchoring pill-taking to an existing routine behavior with the help of small incentives based on principles from behavioral economics in combination with text messages sent by mobile phone. The approach is particularly targeted at those with low motivation and cognitive problems, thereby reducing health inequality and facilitating high, long-term ART adherence for a particularly vulnerable group of HIV clients.